EFFECTS OF ERYTHROPOIETIN ON TRANSFUSION REQUIREMENTS OF NEWBORN

The purpose of this study is to test whether the drug Recombinanat Human Erythropoietin (Epo) can decrease the number of blood transfusions your baby might need during his/her stay in the hospital.